Increasing Nodule Detection in Lung Cancer by Non-Conscious Detection of "Missed" Nodules and Machine Learning

Lung cancer has a 5-year survival rate of 21% and more than 80% of all new patients are diagnosed at an
advanced stage. Finding small lung nodules representing the early stages of lung cancer are critical, but
diagnostic error can be as high as 50% in harder-to-detect lung nodules. Nodule detection is the outcome of a
difficult search task which employs both conscious and non-conscious brain processes that radiologists spend
years of training enhancing. Currently, detection is constrained to those processes that become conscious. A
critical need is characterizing and utilizing these non-conscious processes to improve nodule detection beyond
conscious detection limits. This proposed RO1 will use an innovative new paradigm to isolate non-conscious
processes during lung nodule searches in CT images. Using eye-tracking, the project will show clear and
reliable biomarkers of non-conscious detection for “missed” nodules in the absence of any conscious detection
or consideration of the nodule. These biomarkers will be used to train Machine Learning (ML) to detect
“missed” nodules. The innovation of this application is capitalizing on the full expertise of the radiologist by
utilizing these biomarkers of non-conscious detection to develop ML to read the radiologist and not the image;
disrupting the status quo of ML in radiology, and creating ML that can detect “missed” nodules. The central
hypothesis will be tested in three Specific Aims: 1: To evaluate the extent to which identified biomarkers of
non-conscious detection of missed nodules can be used to train and refine ML models to increase nodule
detection; 2: To quantify the extent that feedback of the locations that ML models indicate are missed nodules
can increase nodule detection; and 3: To specify the extent that trained ML models can generalize to a novel set
of radiologists on a novel set of chest CTs to detect missed lung nodules and increase nodule detection. These
Aims will be carried out by testing radiologist on lung nodule searches in CT images using high-speed eye-
tracking and our innovative paradigm that allow us to isolate non-conscious processes during misses and
demonstrate that non-conscious processes are successfully detecting the “missed” nodules. ML models will be
trained on these non-conscious biomarkers to detect “missed” lung nodules. The ML models will provide
significant feedback to the radiologists to reduce the number of nodules missed by the limits of conscious
detection. The proposed research is significant because it is expected to provide strong scientific justification
for the use of non-conscious processes in diagnostic visual search, and to create ML models capable of
detecting otherwise “missed” lung nodules; hence, changing clinical practice, reducing nodule misses,
improving early detection, and increasing lung cancer's 5-year survival rate.

Public health relevance
Project Narrative The proposed research is relevant to public health because it represents a new and alternative strategy for detecting lung nodules that would have been otherwise missed. This project will show clear and reliable behavioral and physiological biomarkers of non-conscious detection at the location of missed lung nodules using high-speed eye-tracking. These eye-tracking biomarkers of non-conscious detection can be used to train Machine Learning modules to detect the location of missed nodule: disrupting the current standard in Radiology AI by reading the radiologist and not the image, making use of the full trained expertise of the radiologist by tapping into these non-conscious expert processes, and improving detection accuracy and subsequent cancer outcomes beyond that currently constrained by solely conscious recognition. Thus, the proposed research is relevant to the NCI's mission to reduce lung cancer and increase cancer survival rates.